Lesion Composition and Quantitative Imaging Analysis on Breast Cancer Diagnosis

Project Summary/Abstract. Women with dense breast have not been shown to benefit by increased cancer
detection of volumetric digital breast tomosynthesis (DBT) but may benefit by lower recall rates. DBT screening
biopsy rates are similar to 2D digital mammography; higher for first screening exams, lower thereafter with
adjustment for age and breast density. In the U.S., 71% of biopsies do not result in a breast cancer diagnosis
among women ages 40-79 who undergo breast cancer screening. To address the high rate of unnecessary
biopsies, an innovative way to use FDA-approved breast imaging protocols has been developed to acquire
multispectral images to measure the lipid/water/protein (L/W/P) composition of suspicious breast lesions.
Malignant breast tissue has unique L/W/P composition fractions when compared to normal or benign breast
tissue. This proposal aims to increase biopsy yield (BI-RADS-PPV3) through combining L/W/P biological
biomarkers with quantitative morphological and textural image analysis. This combination of composition and
physical descriptions of suspicious breast lesions is called q3CB. The benefits of adding q3CB to the current
DBT screening/diagnostic imaging paradigm, that may already include computer aided detection, is not known.
This study is designed to compare the expected biopsy yield with and without q3CB in a clinical reader study
and explore how q3CB may be combine with existing technologies. The central hypothesis is that biological
L/W/P fractions in breast tissue in combination with analysis of morphological and textural tissue
characteristics will yield significantly higher breast cancer specificity than conventional interpretation of DBT
alone. The objective is to better identify suspicious breast lesions that need to be biopsied for malignancy in
women currently recommended for biopsy. The long-term goal is to reduce unnecessary biopsies and increase
biopsy yield. Our rationale for the proposed research is that biological L/W/P descriptions of breast lesions will
lead to more specific biopsy decisions and a better understanding of cancer types. Specifically, the project
aims are 1) develop q3CB lesion signatures for distinguishing breast cancer lesions from benign lesions, using
600 prospectively-acquired DBT exams of women recommended to undergo biopsy; 2) conduct a clinical
reader study to compare radiologists' performance on standard-of-care FFDM or DBT without and with the
inclusion of q3CB signatures; 3) Investigate the utility of q3CB lesion signatures in a screening paradigm to
improve sensitivity and specificity on CADe-identified suspicious lesions in the tasks of assessing malignancy
as well as in associating with their association with cancer subtypes; Exploratory) explore the added sensitivity
and specificity of dual-energy DBT in phantom studies that explore lesion size, composition, and breast
density. The innovation of this study is the full characterization of lipid/water/protein lesion composition with
DBT and how it complements existing computer aided diagnostic programs paired with clinical radiologists
providing evidence ready for clinical translation of this unique and emerging technology.

Public health relevance
Project Narrative. The proposed studies are relevant to public health because they have the potential to increase the effectiveness of diagnostic mammography and tomosynthesis. Thus, this advance is expected to have a high impact to the health and well being of women because mammography and tomosynthesis are currently the primary diagnostic tools for early breast cancer detection, and over two-thirds of women diagnosed through these imaging modes do not have cancer, resulting in many unnecessary painful invasive procedures. This is relevant to the part of NIH's mission which focuses on the prevention of disease by supporting research in the diagnosis of human diseases.